Deciphering the Dynamic Coordination of Chromatin Accessibility and Gene Expression to Uncover the Mechanisms of Cellular Differentiation

PROJECT SUMMARY
The study of differentiation and development is in many ways the study of how cells change over time. As cells
differentiate and mature, they must change their state by changing their gene expression, chromatin accessibility,
morphology, and other characteristics. These changes both describe and define the steps a cell must pass
through as it differentiates and matures. This proposal seeks to develop computational models that can identify
this sequence of changes that a cell must undergo to mature and transform from one type to another
and compare changes in a cell’s gene expression and chromatin accessibility state in order to see how
these modalities coordinate to drive the maturation and differentiation of a cell.
This will be done by modeling the sequence of cell state changes over time as movement, inferring both the rate
of change within each modality as well as the direction of change, i.e., peaks and genes that define these
changes. Together the rate and direction of change describe a velocity for each cell, showing how the cell
changes as it matures. Recent advances in single cell assay development now allow for the measurement of
both the gene expression and chromatin accessibility modalities from single cells, giving a higher resolution view
into the maturation of a cell. However, current approaches for inferring the dynamics of cell state change either
reveal only the direction of change or cannot be applied equally to each modality. The methods proposed in
this application seek to use the distribution of cells in the cell state space to infer both the rate and direction of
cell state change, allowing these methods to be equally applicable to the gene expression and chromatin
accessibility modalities. This velocity will be inferred with two approaches: (1) For single timepoint datasets,
psuedotime will be used to define the direction of cell state change while the density of cells in each state will
be related to their rate of change; (2) For time series data the change in density over time will be used to describe
the flow of cells down developmental trajectories over time and will be related to a velocity using the drift
diffusion equation.
The algorithms proposed in this application aim to deepen our understanding of development by detailing how
cells change their gene expression and chromatin accessibility as they mature down differentiation trajectories,
by modeling the dynamics of these changes over time in single cell multimodal data. Further, these algorithms
will provide a toolkit to explore the coordination between the epigenome and transcriptome, offering insights into
cell fate priming and plasticity. This will lead to a better understanding of cell fate specification and will enhance
our ability to design therapies for developmental diseases and uncover new targets for human reprogramming
and regeneration.

Public health relevance
PROJECT NARRATIVE: The core questions of developmental and regenerative biology are: (1) What sequence of changes to cell state describe a cell's progression from a multipotent stem cell to each terminal fate, and (2) what factors and mechanisms control these changes? This proposal outlines new algorithms that use single-cell paired chromatin accessibility and gene expression data to model cell state dynamics, identify key regulatory factors, and compare dynamics across modalities giving insight into these key questions. This work will enhance our understanding of development, regeneration, and reprogramming, and improve our ability to control cell fate to avoid disease and replace damaged cell types or tissues.